TASK ORDER 75N95022F00001 (GLP INTERACTION SAFETY STUDIES IN RATS AND DOGS) UNDER IDIQ NO. HHSN271201800019I. 11/17/2021 - 5/16/2024.

The National Institute on Drug Abuse (NIDA) is a United States federal government research institute whose mission is to "advance science on the causes and consequences of drug use and addiction and to apply that knowledge to improve individual and public health."